Investigating tau and ApoE4-mediated alterations in oligodendrocyte progenitor cells

PROJECT SUMMARY/ABSTRACT
As the most common cause of dementia, Alzheimer’s disease (AD) is pathologically defined by amyloid beta
(Aβ) deposition in senile plaques and tau aggregation in neurofibrillary tangles (NFTs). In addition to
amyloidosis and tauopathy, demyelination is also a consistent, yet often overlooked, feature of AD. Notably,
myelin loss is detected even at early stages of disease with decreases observed in patients with mild cognitive
impairment (MCI). This implicates that dysregulation of the oligodendrocyte cell population, the brain’s myelin-
producing cells, may be a critical factor in AD pathophysiology. Several recent studies from multiple groups
consistently identified transcriptional alterations in myelination networks as a key feature of AD, underscoring
the great need to elucidate disease-related alterations in the oligodendrocyte population to provide novel
insights into AD pathophysiology. Of particular relevance, tau accumulation is associated with loss of white
matter integrity in both human patients and mouse models of tauopathy. White matter abnormalities have even
been detected in cognitively-normal carriers of the apolipoprotein E ε4 (APOE ε4) genotype, a population at
high risk of developing AD. Given that ApoE4 has been shown to potentiate tau toxicity and ischemia-induced
white matter damage in mice, these findings may indicate that tau burden and ApoE4 converge to drive white
matter abnormalities in AD. Considering that oligodendrocyte progenitor cells (OPCs) respond to white matter
damage by migrating to the site of injury and differentiating into myelinating oligodendrocytes to repair the
lesion, a key question is why OPCs and/or oligodendrocytes fail to correct white matter abnormalities in the
presence of abnormal forms of tau and/or ApoE4. A recent study found that OPCs in both postmortem brain
and a mouse model of AD exhibited markers of cellular senescence, with pharmacologic removal of senescent
OPCs alleviating inflammation and cognitive defects in mice. These results provide compelling evidence that
OPC dysfunction may actually contribute to and exacerbate disease progression in AD. As such, the current
study will investigate the impact of tau pathology and APOE genotype on abnormalities in OPCs and
oligodendrocytes, including remyelination ability. In addition, given that deletion of the ApoE receptor, Lrp1,
from OPCs provided neuroprotection, stimulated myelin repair and reduced inflammation in mouse models of
demyelination, we will evaluate the protective effect of Lrp1 deficiency in OPCs in the context of tauopathy, as
well as the role in exacerbation of tauopathy in the presence of ApoE4. Collectively, the current project will
identify key functional and transcriptional alterations observed in the OPC/oligodendrocyte population in
response to tauopathy and ApoE4, and determine whether loss of Lrp1 in OPCs mitigates ApoE4-mediated
exacerbation of tau pathology.

Public health relevance
PROJECT NARRATIVE There is growing evidence that defects in myelination, a process that insulates neurons and facilitates brain activity, may be an important aspect of Alzheimer’s disease (AD) pathology. Oligodendrocyte progenitor cells (OPCs) give rise to oligodendrocytes, the myelin-producing cells of the brain, and have recently been shown to become dysregulated during pathology, exhibit toxic functions and shape chronic disease. The current project will investigate how alterations in OPCs and mature oligodendrocytes are affected by two factors closely linked to AD (tau and ApoE4), to shed new light on a novel, disease-causing role for OPCs in AD progression.